Attention Training for Adolescents with Soical Anxiety Disorder

DESCRIPTION (provided by applicant): The primary objective of this study is to develop an Attention Training (AT) protocol for adolescents with social anxiety disorder (SAD). Attentional biases to threat have been shown to be associated with the development and maintenance of anxiety disorders, in both adults and youth (Bar-Haim et al., 2007; Cowart & Ollendick, 2010; Perez-Edgar et al., 2010; Schechner et al., 2011). Given these relations, AT paradigms have been developed to modify these attentional biases. Such paradigms have been shown to be promising in the treatment of adult anxiety (Amir et al, 2009; Buckner & Timpano, 2009; Klumpp & Amir, 2010; MacLeod & Bridle, 2006; Richey & Schmidt, 2006). However, to date, only two small studies have examined the use of AT with children, and no ATT protocol has been developed specifically for use with children or adolescents. This is important, given the complications and possible ineffectiveness of applying adult-designed therapies to youth (Ollendick & Vasey, 2001). Given this gap in the literature, the primary aims of the current study are intended to develop a treatment program to address attentional biases and anxiety in adolescents with SAD, to collect preliminary data regarding the program's short-term efficacy and feasibility, and to explore attention biases as a mediator and moderator of initial treatment outcomes. It is hypothesized that the AT protocol developed in the current project, compared to a placebo control comparator condition, will result in reductions in social anxiety among a sample of adolescents with SAD. Further, the AT protocol is expected to reduce attentional biases to threat among those adolescents who possess such biases prior to treatment (not all adolescents are expected to show this bias yet AT has been shown to be potentially effective with these youth; the presence/absence of attention bias will be explored as a moderator of change). The proposed study will be a pivotal step towards assessing the feasibility of an adolescent-focused AT procedure for the treatment of SAD. Results will contribute to an emerging body of research exploring the ameliorating effects of experimental paradigms that target information processing biases in anxious youth. Given emerging evidence regarding the use of AT in adult populations, findings from this study may have implications for improving the current prevention and treatment options available for anxious adolescents.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed study represents one of the first known attempts to treat anxiety in socially anxious adolescents through the modification of attentional processing using attention training. This treatment has the potential to be more acceptable to socially anxious adolescents as compared to traditional treatments because of its brief, computer-based nature. As such, we believe this will significantly advance access to treatment in this population.